OPIATE DEPENDENCE PHARMACOTHERAPY MAINTENANCE EFFECTS ON ZIDOVUDINE (AZT)

We are conducting this study to determine whether other drugs used to treat opiate dependence have significant effects on AZT disposition. The proposed studies represent a method for identification of potential drug interactions in the AIDS population, which is cost-effective. These investigations will make a significant contribution to improve medical and substance abuse treatment in opioid-dependent patients with HIV disease.